Time Restricted Eating intervention for Alzheimer's disease (TREAD)

SUMMARY
Alzheimer’s disease (AD) is a devastating neurodegenerative disorder affecting the lives of more than 5
million Americans and their families and is the biggest forthcoming health challenge. AD is a multifactorial
disorder manifested clinically by progressive memory loss, decline in cognitive functions and ultimately leading
to dementia. Despite being the subject of intense research, there is no cure for AD, therefore, identifying
therapies that can reduce disease progression at early stages is critical.
Circadian impairment is a major feature of Alzheimer’s disease. Behavioral circadian alterations, known as
sundowning, are experienced by more than 80% of patients and represent the leading factor for hospitalization
and nursing home placement in AD. New research suggests that circadian disruption occurs early during
disease progression and contributes to neurodegeneration. Since circadian rhythms regulate multiple systems
in the human body coordinating physiology with the environment, alterations in this system have a profound
impact on health, behavior, sleep, and cognition. The proposed work will conduct a preliminary investigation on
the beneficial effects of regulating the time of food intake to improve circadian function, on cognition and
disease markers in Mild Cognitive Impairment (MCI) or AD patients.
One of the most powerful regulators of the circadian system is the daily feed/fast cycle. We recently
demonstrated that time-restricted feeding (TRF) improves key disease components including memory, sleep,
behavior, disease pathology, and brain transcription in mouse models of AD. Notably, we found that TRF had
the remarkable capability of simultaneously reducing amyloid deposition, increasing Aβ42 clearance, improving
sleep and hyperactivity, and normalizing transcription of circadian, AD, and neuroinflammation-associated
genes in AD mice. Thus, our study unveiled for the first time that circadian modulation through timed feeding
has far-reaching effects beyond metabolism and affects the brain as the substrate for neurodegeneration. A
similar intervention in human patients may have a profound translational value, addressing the crucial need for
accessible approaches to reduce or halt AD progression.
We now propose to test the safety, feasibility, and effectiveness of a time-restricted eating (TRE) paradigm in
patients with a clinical diagnosis of cognitive impairment due to MCI or AD. We will recruit 40 patients and
randomize them into two groups that will follow a TRE model of prolonged fasting during the night (14h without
food intake) for 6 or 12 months. We will monitor blood-based markers of health, metabolism, epigenetic aging,
and AD pathology; record circadian regulation based on sleep and activity monitoring and evaluate cognitive
functions. The data collected will be fundamental to designing a larger clinical trial using TRE to improve
circadian function and reduce cognitive and pathology burden in AD. Since this is a safe intervention that does
not require drugs or special equipment, this intervention will be immediately available for millions of patients.

Public health relevance
Project Narrative Alzheimer’s disease (AD) affects more than 5 million Americans over the age of 60 and manifests with progressive memory loss, decline in cognitive abilities, and altered circadian regulation, which affects sleep- wake patterns and behavior and represents the main factor of hospitalization and morbidity. The daily feed/fast cycle is a powerful regulator of the circadian system, and we recently demonstrated that time-restricted feeding improves key disease components including memory, sleep, disease pathology, and brain transcription in mouse models of AD. We will investigate the safety, feasibility, and effectiveness of prolonged night fasting in reducing cognitive decline and disease markers in patients with cognitive impairment due to AD.